The role of retinoic acid signaling in patterning the human cerebral cortex

ABSTRACT/PROJECT SUMMARY
This application presents a five-year mentored research and training plan that will prepare Dr. Cathryn
Cadwell to be a leader in the field of cortical development and circuit assembly. Dr. Cadwell completed her MD
and PhD in Neuroscience at Baylor College of Medicine, where she studied the role of cell type and cell
lineage in shaping cortical circuits in the lab of Dr. Andreas Tolias, and is now completing her clinical fellowship
in Neuropathology at the University of California, San Francisco. Dr. Cadwell’s long-term career goal is to
advance our understanding of the pathological processes underlying neurodevelopmental and neuropsychiatric
disorders. This project will facilitate foundational discoveries for her independent research program, as she
seeks to delineate the mechanisms and functional consequences of cortical areal specification.
Different areas of the human brain give rise to unique cognitive abilities. For example, expansion of the
lateral prefrontal cortex (PFC) in humans is thought to underlie higher-order cognitive processes such as
decision-making, planning and working memory. Recent data has implicated retinoic acid (RA), a derivative of
vitamin A, as a key player in the early development of the PFC in humans; however, the precise mechanism by
which RA specifies PFC identities is unknown. This proposal leverages a human induced pluripotent stem cell–
derived cerebral organoid model, which recapitulates many aspects of early human brain development, to test
the hypothesis that RA acts in a cell type–specific manner to specify PFC identities. Using this model, Dr.
Cadwell proposes to 1) identify the nuclear receptors and gene regulatory elements that mediate RA signaling
in human cortical progenitors and 2) determine whether PFC-like areal fate is stable after RA induction. This
work will generate fundamental knowledge about the role of RA in patterning the cerebral cortex, and may
provide insights into neurodevelopmental disorders associated abnormal cortical areal specification.
The proposed career development plan includes training in cerebral organoid models, epigenetic
techniques and analysis of large-scale data sets. Dr. Cadwell will learn all of the skills needed for an
independent research career, including supervising trainees and staff, grant writing, and scientific
communication. She has assembled a world-class mentorship team with complementary expertise in
organoids and human brain development (Primary mentor, Dr. Tomasz Nowakowski), molecular mechanisms
of cortical development and patterning (Co-mentor Dr. John Rubenstein and Advisory Committee Member Dr.
Sam Pleasure), gene regulation (Advisory Committee Member Dr. Nadav Ahituv), analysis of large-scale
genomic data (Dr. Katie Pollard), and neuropathology of neurodevelopmental disorders (Dr. Eric Huang). Dr.
Cadwell, her mentors, and the Department of Pathology at UCSF are fully committed to this proposal and to
her goal of becoming an independent physician-neuroscientist by the completion of this training period.

Public health relevance
PROJECT NARRATIVE Different areas of the brain are composed of unique cell types and connectivity patterns that subserve their unique functional roles, and disruption of areal patterning during development can lead to neurologic and neuropsychiatric disorders such as autism and schizophrenia. Recent studies have implicated a role for retinoic acid, derived from Vitamin A, in patterning of the cerebral cortex, and this proposal will explore the mechanism by which this areal specification occurs. These experiments will generate foundational knowledge about the mechanisms of areal specification in the brain, and may help explain genetic susceptibility to neurodevelopmental disorders associated with abnormal arealization.